Parathyroid Hormone Receptor Type 1: Dynamics, Traffic and Recycling

The traffic and fate of internalized G protein coupled receptors (GPCR) play a central role in the regulation of their function. Although the general pathways of GPCR internalization are shared among most members of the family, the precise mechanisms by which these pathways are regulated remain elusive. An extreme example of this is the Type I parathyroid hormone receptor (PTH1R). The PTH1R exhibits remarkable celland tissue-specific differences regarding the regulation of its activity and traffic by different ligands. Previous work from our laboratory and others has shown that the PTH1R is internalized by a combination of arrestindependent and independent processes. However, the relative contributions of these processes and the mechanisms that regulate them are still largely unknown. This application will test the hypothesis that PTH1R internalization is tightly regulated by the interactions of the PTH1R with PDZ (PSD95, discs-large, Zo-1) proteins. Abundant preliminary work presented here shows that the traffic the PTH1R is regulated by the PDZ proteins NHERF1 and Dvl2. This proposal will address the mechanisms by which these regulatory proteins perform their function in bone cell models. These studies will be conducted using state-of-the-art imaging (time-lapsed confocal and total internal reflection microscopy, single molecule tracking, and image correlation spectroscopy) in combination with classical membrane biochemistry and molecular biology strategies (analysis of the behavior of point mutants, ligand binding studies, immunoprecipitation techniques). A major innovation of the approach proposed is that it relies substantially on the analysis of individual endocytic steps to complement the global biochemical analyses. The tools developed and the conclusions obtained from this work will have applications to other members of the GPCR family.

Public health relevance
Project Narrative: Parathyroid hormone (PTH) is the main regulator of calcium metabolism in the body. Its actions are mediated by the Type I PTH/PTHrP receptor (PTH1R). This receptor regulates extracellular calcium and phosphate homeostasis via its primary actions in kidney and bone. After PTH1R binds the hormone, several downstream signaling cascades are initiated in the target cell. These signals are usually terminated by the internalization of the receptor, which is later recycled to the cell surface for subsequent rounds of function. Unlike many other hormone receptors, the function and traffic of PTH1R is strikingly cell-, tissue-, and ligand-dependent. These differences are not due to intrinsic differences in the receptors expressed in different cells. This proposal will examine the mechanisms by which two important regulators of receptor traffic modulate the dynamics, internalization and recycling of the PTH1R in response to different classes of ligands. The outcome may suggest additional mechanisms that cause PTH resistance, especially during advanced chronic renal failure or renal osteodystrophy.